Innate Immune Mechanisms Governing Subclinical Malaria in Children

ABSTRACT
Subclinical (asymptomatic) malaria with Plasmodium falciparum (Pf) is common in children who live in moderate-
to-high transmission areas of sub-Saharan Africa. Although subclinical malaria may be submicroscopic, affected
school-age children (ages 8-15 years) often have positive blood smears that include millions of parasites per mL
of blood. While subclinical malaria is typically attributed to acquired adaptive immunity that tightly controls the Pf
biomass, patent parasitemia (blood smear+) exceeds any reasonable estimate of the pyrogenic threshold. How
is it possible to remain without fever and overt malaria symptoms with patent parasitemia? In contrast to
symptomatic malaria, temporally persistent (chronic) subclinical malaria seems to be maintained by a complex
balance of pro-inflammatory and anti-inflammatory cytokines and immune cells. The scientific premise of this
proposal is that epigenetic modifications of innate immune cells, including blood monocytes (Mo), modulate
inflammatory pathways underlying subclinical malaria. Furthermore, we hypothesize that an immune
homeostasis network involving anti-inflammatory Pf-induced type 1 T regulatory cells (Tr1) and IL-10 as well as
enhanced IL-1RA production suppress innate immune inflammatory pathways. Subclinical malaria is of high
epidemiologic significance as parasitemia persists for months in schoolchildren who serve as the major reservoir
of gametocytes required to sustain Pf transmission to local anopheline vectors. Indeed, it is estimated that ~
60% of new mosquito infections can be attributed to this demographic. To test our hypotheses, we will enroll
Kenyan schoolchildren (ages 8-15) in a longitudinal cohort study to compare and analyze differences in immune
parameters between those with A) chronic subclinical malaria (Pf+ smear at baseline and who remain afebrile
despite repeatedly smear+ x 16 weeks) relative to B) children who develop febrile clinical malaria up to 2 weeks
after an afebrile Pf+ smear. The specificity of immune parameters for chronic Pf exposure in these cohorts will
be interrogated by comparison to age and sex matched children residing in a nearby highlands area where
malaria endemicity is ~ zero. PBMC and isolated Mo from children will be analyzed by RNA-seq to determine
activated gene expression pathways. We will define the differences in immune cell subsets, the transcription
factors that are activated and their effector cytokine expression profiles using mass cytometry (CyTOF). In
addition, we will use chromatin immunoprecipitation (ChIP) DNA sequencing to determine if the epigenomes of
children with chronic subclinical malaria are modified in order to silence proinflammatory genes or conversely,
to activate anti-inflammatory ones. Finally, we will identify and compare by Assay for Transposase-Accessible
Chromatin with high-throughput Sequencing (ATAC-seq) open chromatin sites in key gene expression pathways
in Mo from the comparator groups and align these regions with RNA-seq data from the same child. The
successful completion of this project should give us new and important insights as to the mechanism of
subclinical malaria and how this disease state can be modified to facilitate malaria eradication.

Public health relevance
NARRATIVE This research has high public health significance in malaria endemic regions of sub-Saharan Africa since it will advance our understanding of the innate immune mechanisms by which chronic Plasmodium falciparum blood stage infection is maintained in healthy asymptomatic school-age children. Children in this age group are the single most important reservoir of ongoing P. falciparum transmission to mosquito vectors. Results of this study are pertinent to the control and ultimate elimination of malaria.